Alcohol and Immunology Research Interest Group (AIRIG) Meetings

This R13 meetings grant application seeks partial support for three upcoming annual Alcohol and Immunology Research Interest Group (AIRIG) meetings in conjunction with either the Midwest Autumn Immunology Conference (AIC) in Chicago, IL, the Research Society on Alcoholism (RSA), the Society for Leukocyte Biology (SLB), the Shock Society or Keystone Symposia. Funding is requested to cover travel costs and housing for students, postdoctoral fellows, junior faculty, and meritorious scientists, as well as some of the costs for invited speakers, for a one-day meeting which will cover broad aspects of alcohol and immunology. The 2023 AIRIG meeting will be held at the University of Colorado Denver (UCDenver) Anschutz Medical Campus on Friday December 8, 2023.The topic will be “Alcohol, Infection & Immunity.” This full-day AIRIG meeting will include 3 plenary sessions: 1) Alcohol, infection and host immunity, 2) Alcohol, inflammation and tissue damage, and 3) Alcohol and the gut-brain axis, along with posters, short presentations selected from submitted abstracts and a lunch time mentoring/educational workshop. We will hold the 2024 AIRIG meetings at Loyola University Chicago (Loyola) and 2025 AIRIG meeting as a satellite in conjunction with the RSA meeting in New Orleans, LA. Themes of the latter two meetings will be “Alcohol, Inflammation and Tissue Injury” and “Alcohol and Multi-Organ System Responses.” The 2024 meeting will be held the day before the annual meeting of the AIC. The AIC is a regional meeting with an impressive list of invited plenary speakers and ~440 registrants, while RSA meetings are much larger, especially when held along with ISBRA. Holding the AIRIG meeting with AIC and RSA will allow greater visibility of alcohol and immunology research. Additionally, these meetings have numerous opportunities for young developing scientists to participate on many levels, including selecting a large number of oral presentations selected from submitted abstracts. In addition, these meetings have Career Development Programs, including sessions on Grant Writing. These sessions allow time for career building and collaborative opportunities, which may not be feasible or readily available at other meetings. Thus, in addition to providing a forum for the discussion of current research in the field, overall goals of the co-organizers are to expand the participation of students, postdoctoral trainees, and other meritorious scientists and to increase the critical mass of scientists working on alcohol and immunology issues. We believe that these goals will be best achieved by scheduling upcoming AIRIG meetings in conjunction with the AIC and RSA.

Public health relevance
There are a limited number of laboratories working in the field of alcohol and immunology, all of which benefit from the AIRIG meetings, as the meetings provide a forum for maintaining an open dialog between these research groups. The meetings are intended to be inclusive: 1) bringing research groups together to foster communication and collaboration, 2) allowing junior scientists and those who are new to the field to present their work orally, and 3) introducing alcohol trainees to senior alcohol research faculty who may be able to serve as future mentors to the trainees. The organizers feel that meeting in a friendly, non-competitive setting increases the potential for rapid scientific advancement and may help to keep alcohol and immunology trainees in the field by availing them of the opportunity to meet funded senior faculty and their trainees.